Testing hybrid theories of action-selection

Project summary
Current theories suggest that mammalian behavior arises from an interaction of different action-
selection systems that process information about the past (memory), present (perception), and future
(goals to achieve, outcomes to avoid) differently. Current theories dichotomize systems into planning
and procedural systems, but newer theories suggest more complex, hybrid algorithms may exist within
mammalian decision-systems. Current views of psychiatry are based on dysfunctions in the information
processing of those decision systems, which means that treating and alleviating those disorders will be
enhanced by a better understanding of the information processing that underlies decision making. A
number of disorders (OCD, eating disorders, drug addiction) and a number of RDOC-related dysfunctions
(compulsivity, habits, and issues of cognitive and “self-” control) have all been proposed to depend on
conflicts between these decision systems. We will build on our established expertise in neural ensemble
recording and computational analysis to examine the information processing of decision systems,
particularly in questions of conflicts between these systems. Using DREADD manipulation and neural
ensemble recording technologies, we propose to identify the mechanisms and computations that
underlie action-selection processes under exogenously and internally-driven strategy changes.

Public health relevance
Project Narrative Current theories dichotomize decision-making into planning and procedural information processing, but newer theories suggest more complex, hybrid algorithms may exist within mammalian decision-systems. Understanding the information processing within these decision-systems is critical to help recognize and alleviate disorders that arise from imbalances and dysfunctions within those decision-making systems (such as OCD, eating disorders, and drug addiction) and can also help us develop new behavioral “nudges” that can guide behavior.